Integrated analyses of the epigenome to understand the molecular basis of hematopoietic malignancies

PROJECT SUMMARY
Research Plan: An impaired hematopoietic differentiation process underlies bone marrow malignancies like
leukemia, but we still lack the mechanistic understanding of the sequence of regulatory events that misleads the
differentiation process. Since epigenomic regulatory patterns are major features of leukemic development,
understanding the chromatin dynamics of a failed (malignant) hematopoietic differentiation process can help
define the molecular basis of leukemia. A prerequisite to such an understanding is a framework that allows
investigation of the progressive changes in the activity of the regulatory elements (RE) during hematopoietic
differentiation. Single-cell CUT&Tag (scCUT&Tag) technology is well-suited for such studies as RE activity
through histone modification profiles can be investigated in a lineage-specific manner. However, poor
understanding of the cell-type-specific histone modification patterns makes the task challenging. To overcome
this challenge, we designed scCUT&Tag-pro which allows simultaneous measurement of cell-surface protein
and in-silico integration of gene-expression and chromatin accessibility. I will leverage this novel multimodal
framework to investigate the RE and progressive changes in their activity during hematopoiesis. First, I will define
a multimodal reference mapping framework for mouse hematopoiesis. This framework will allow me to integrate
multiple histone modification profiles onto one reference and compare the chromatin states of the RE between
a wild type (WT) and mouse model with loss of function in histone methyl transferase (HMT) (Aim 1). Second,
since HMTs regulate transcription through the interaction network of RE. I will define a chromatin state aware
map that dynamically links REs across developmental trajectories. I will use this framework to investigate the
changes in the interaction of REs due to HMT loss (Aim 2). Third, since the transcriptional state of a cell emerges
from the underlying gene regulatory network (GRN), I will integrate single-cell gene expression data with histone
modification profiles and extend it to define a chromatin state aware model of GRN. I will compare the WT and
HMT loss experiments and define the differential GRN (Aim 3). Altogether, this research proposal seeks to
pioneer the computational methods for the integrated analyses of multimodal single-cell histone modifications
and systematically dissect progressive changes in the system-level function of the regulatory circuits that
misleads hematopoietic differentiation using mouse models with conditional HMT loss of function in the
hematopoietic compartment. I have developed a 5-year career development plan to meet my goal of becoming
an independent investigator in the multi-disciplinary field of computational cancer biology. The mentorship
committee will also provide me the guidance in my research and academic job search. Given the excellent the
outstanding record of training multiple independent scientists, New York Genome Center provides me an ideal
environment to attain my scientific career goals.

Public health relevance
PROJECT NARRATIVE An impaired hematopoietic differentiation process underlies bone marrow malignancies like leukemia, but we still lack the mechanistic understanding of the sequence of regulatory events that misleads the differentiation process. Understanding the chromatin dynamics of a failed (malignant) hematopoietic differentiation process, in comparison to a healthy process, can define the molecular basis of leukemia. This research proposal seeks to develop a suite of computational tools for the multimodal integration of epigenomic data and use the framework to mechanistically investigate the corrupted hematopoietic differentiation process through mouse models of leukemia.